Tumor Biology Program

PROJECT SUMMARY – Tumor Biology Program
The Tumor Biology Program is one of two basic science Research Programs of the Abramson Cancer Center
(ACC). This Program aims to catalyze research within the ACC to advance an understanding of mechanisms
underlying tumorigenesis and to identify pathways that will enable novel preventive, diagnostic, prognostic and
therapeutic approaches to cancer. Since its inception in the early 1970s, the Tumor Biology Program has
continued to respond to emerging areas and advances in cancer research. The Program is currently organized
around three central Aims: 1) Elucidate the molecular and cellular basis underlying cancer; 2) Understand the
epigenetics of cancer; and 3) Investigate the tumor microenvironment and metastatic progression. Members of
Tumor Biology are highly interactive, collaborating intra-Programmatically across scientific topics relevant to
each Aim including genome integrity, cell signaling, metabolism, and viral pathways, with an eye on cancers of
highest burden or health disparity in our catchment area. Ground-breaking discoveries in Tumor Biology
uncovered novel mechanisms of epithelial-mesenchymal transition, transcriptional control of cancer drug
sensitivity, epigenetic regulation of inflammation, novel mechanisms of androgen-resistance in prostate cancer,
and immune evasion by viral mimicry. New targets were translated to the clinic in collaboration with other
Programs for early detection and treatment. The Tumor Biology Program is led by new and energetic Program
co-Leaders (PLs) Shelley Berger, PhD and Sandra Ryeom, PhD, who together catalyze impactful intra- and
inter-Programmatic collaborations by a variety of innovative methods. The PLs are instrumental in recruiting
new members, mentoring junior faculty, stimulating interactions and meetings among faculty members, and
organizing conferences and symposia. Tumor Biology Program members play key roles in the training and
mentorship of high school students, PhD students, MD/PhD students, and MD or PhD postdoctoral fellows in
cancer-related research through their leadership roles in the University of Pennsylvania Biomedical Graduate
Studies (BGS), MD/PhD program (MSTP) and NIH T32 training grants. The continued success of the Tumor
Biology Program is evidenced by the exceptional scientific progress of its members, demonstrated through
high-impact publications with multi-institutional, inter- and intra-Programmatic collaborations, offering key
insights into the biology of cancer. Currently, the Program has 53 members from 20 departments and five
different schools with total funding of $25.7M (annual direct costs) of which 20.0M is peer-reviewed and $6.4M
is NCI-funded. The Program has 67 R01-equivalents. Since 2015, Tumor Biology Program members published
617 cancer-related papers, of which 15% were intra-Programmatic, 29% were inter-Programmatic, and 62%
were multi-institutional.